Diversity Supplement: SCH: Personalized Rescheduling of Adaptive Radiation Therapy for Head and Neck Cancer

Project Summary
No changes from original grant R01CA257814.

Public health relevance
Project Narrative No changes from original grant R01CA257814.